Translational inhibition by Schlafen proteins during the DNA damage response

Recently, human Schlafen 11 (SLFN11) - which we had shown to inhibit HIV protein expression due to the
distinct codon-usage bias of the virus – was found to determine cell fate after exposure to DNA-damaging
agents (DDAs). Cells lacking SLFN11 are resistant to DDAs, but not to other chemotherapeutic drugs. As
DDAs are the largest group of cancer drugs, resistance against them impacts a large patient population and
thus it is vital to unravel Slfn11's molecular contribution to the efficacy of DDAs, and to restore it in cells w/o
Slfn11. So far, the events by which loss of SLFN11 causes resistance to DDAs remained unanswered.
We now show that SLFN11 inhibits ATR translation in response to DDAs to enhance cell killing. This
discerning inhibition translation is due to the prominent use of specific Leu codons in ATR. SLFN11 inhibits
translation when Leu is (frequently) encoded via TTA or CTT, but not when other codons are employed. We
demonstrate DDA-induced, SLFN11-mediated cleavage of a distinct tRNA subset including tRNAs Leu-TAA
and Leu-AAG. DDA sensitivity in Slfn11-deficient cells can be restored 1) by abrogation of ATR expression; 2)
through inhibition of ATR kinase activity; or 3) through the use of Gapmers, a novel technology we adapted to
selectively target tRNA Leu-TAA for degradation. We note a novel mechanism of codon-specific regulation of
translation by SLFN11 in the DNA damage response exists and provides the first evidence that modulation of a
distinct tRNA allows for targeting specific proteins relying on those tRNAs. We provide proof-of-concept that
targeting tRNAs by Gapmers is a valid approach to manipulate actions such as cell survival or viral replication.
Our overarching goal is to improve our understanding of the function and regulation of Slfn11 during the
DNA damage response on a cellular and molecular level. Aim 1 focuses on the analysis of Slfn11 itself,
exploring its functional domains and regulation. We already identified several inhibitory phosphorylation sites in
Slfn11 implying that dephosphorylation is required for SLFN11 activation, and show that PP1Cγ is the
activating phosphatase during the DNA damage response. These findings need to be verified and expanded
upon in additional settings (Other cell types and DDAs? Check for possible additional (de)phosphorylation
sites? Identify likely cofactors?)
The experiments outlined in Aim 2 target the role of the tRNA cleavage (identify cleavage site(s); test
potential requirement for post-transcriptional modifications of tRNAs; do cleavage-resistant tRNA Leu-TAA
mutants render cells DDA-resistant, and do such “mutants” exist in nature? Possible biological function for the
tRNA-derived nucleic acid fragments?).
Successful completion of the proposed studies will support the notion that SLFN11-deficient cancer cells
can be (re)sensitized to DDA therapy by targeting ATR or distinct tRNAs, and that suppression of specific type
II tRNAs might offer a new strategy to overcome resistance to DDAs. Finally, in our HIV studies we found that
SLFN11 inhibited the translation of viral proteins during retro/lenti-viral infections, but not other viruses. We
now think that the reason for this phenomenon is that retro-viruses cause DNA damage during integration,
thereby likely activating SLFN11. In contrast, e.g. Influenza (despite similarity in codon bias to HIV) was not
inhibited by SLFN11. We hypothesize now that SLFN11 might actually inhibit Influenza or other “biased”
viruses if SLFN11 is independently activated by pharmacological means.

Public health relevance
Cancer continues to be one of the leading causes of death in the US, and one of the great mysteries is how certain tumor cells are or become resistant to specific chemotherapeutic agents, and how sensitivity might be restored. In the course of previous work we defined the protein SLFN11 as cellular factor that inhibits the production of HIV by inhibiting the synthesis of viral proteins, and we now have proof that SLFN11 inhibits in a similar manner the synthesis of cell survival factors after exposure to specific chemotherapeutic agents; consequently, the loss of Slfn11 in cancer cells allows for the enhanced production of these survival factors and thus resistance to the drug treatment. The proposed studies will investigate the mechanism by which Slfn11 selectively inhibits protein synthesis, explore the diagnostic and prognostic value of Slfn11 in selecting effective treatment strategies, and delineate ways to overcome the drug resistance associated with the loss of Slfn11.